Investigating Oatp-Mediated Delivery of Statins to the Brain in Males and Females: Relevance to Neuroprotective Treatment for Ischemic Stroke

PROJECT SUMMARY
Stroke is the fifth leading cause of death in the United States. Approved stroke therapies are limited by narrow
treatment windows, the risk of hemorrhagic transformation, and reperfusion injury. Therefore, there is a critical
need for neuroprotective drugs that can improve post-stroke neurological performance. Currently, 3-hydroxy-3-
methylglutaryl coenzyme A (HMG CoA) reductase inhibitors (i.e., statins) are given to stroke patients due to their
proven utility in improving cognitive and motor outcomes. Studies in our laboratory have uncovered a specific
biological mechanism that enables statins to be effective drugs for stroke treatment: transport across the blood-
brain barrier (BBB) via the endogenous uptake transporter organic anion transporting polypeptide 1a4 (Oatp1a4).
We have shown, for the first time, that Oatp-mediated transport is required for atorvastatin to reduce cerebral
infarction volume and improve sensorimotor performance at 24 h following transient middle cerebral artery
occlusion (tMCAO). We also observed increased atorvastatin uptake in female rats subjected to tMCAO as
compared with their age-matched male counterparts; however, it is unknown if these differences in Oatp-
mediated transport at the BBB cause variations in atorvastatin’s ability to prevent stroke progression and/or
worsening of neurocognitive deficits in the acute/subacute period. Our goals are to assess the role of sex as a
biological variable on statin transport in the ischemic brain and to determine how these differences affect statin
efficacy as stroke therapeutics. The central hypotheses of this F31 application are i) that functional
expression of Oatp1a4 at the BBB is different in males as compared to females following tMCAO; and ii)
that statin neuroprotective properties and/or their effects on post-stroke neurological outcomes are
influenced by sex-dependent differences in BBB Oatp1a4 activity. Two aims will test these hypotheses:
Aim 1: Investigate sex-dependent differences in Oatp1a4-mediated transport of statins at the BBB in
stroke. We will perform our studies in male and female SD rats using the tMCAO model. Oatp1a4 localization
and protein expression will be assessed using confocal microscopy and western blotting, respectively. Blood-to-
brain transport of statins will be measured using in situ brain perfusion, a state-of-the-art methodology to study
drug transport at the BBB.
Aim 2: Evaluate sex-dependent differences in statin-associated neuroprotection and functional
neurological recovery in stroke. In tMCAO operated male and female SD rats, we will use confocal microscopy
and western blot analysis to examine molecular biomarkers associated with neuroprotection. We will also assess
motor and cognitive performance in tMCAO-animals using robust behavioral tests (i.e., rotarod analysis, Morris
Water Maze, Novel Object Recognition test).
Overall, this project will provide critical mechanistic data on efficacy of statins as neuroprotective drugs for stroke.
Furthermore, this project directly aligns with NIH goals in studying sex as a biological variable in stroke.

Public health relevance
PROJECT NARRATIVE Our laboratory has uncovered organic anion transporting polypeptide 1a4 (Oatp1a4) as a critical blood-brain barrier (BBB) mechanism that enables 3-hydroxy-3-methylglutaryl coenzyme A (HMG-CoA) reductase inhibitors (i.e., statins) to function as effective therapeutics in ischemic stroke. In this proposal, we will study differences in Oatp1a4-mediated transport in male and female animals that are subjected to transient middle cerebral artery occlusion (tMCAO) in order to understand how sex differences can affect statin therapeutic effectiveness in stroke. This work will directly impact public health in the United States by showing how sex as a biological variable must be considered in development of effective neuroprotective treatment strategies for ischemic stroke.